CE19-001, The Columbia Center for Injury Science and Prevention (CCISP)

Columbia Center for Injury Science and Prevention – Project Summary
The Columbia Center for Injury Science and Prevention will build upon its many past successes as
a previously funded CDC Injury Control Research Center (ICRC) yet, at the same time, will thoughtfully
progress into important new directions in seeking to usher in a new era of injury science. The Center will
do this by promoting and performing innovative, cutting-edge injury research with real-world impact;
building a new generation of injury scientists and practitioners in one of the world's leading training
programs; and engaging in bidirectional sharing of expertise with policymakers and community partners to
meaningfully reduce the burden of injuries and violence. The Center will integrate and sustain these three
core activities — research, training, and outreach — to maximize its impact far beyond what would be
achieved in separately conducting these activities.
The overall objective of the Columbia Center for Injury Science and Prevention (CCISP) will be
“science in service to safety”, leveraging the unique value of scientific inquiry in assembling a large group
of university, community, and government partners around injury and violence strategies with the greatest
potential to innovatively impact the safety and health of large populations. The proposed Center will meet
this objective through multiple efforts that: 1) further develop infrastructure that brings together scientific
expertise, policy, and practice; 2) create diverse, interdisciplinary collaborations and far-reaching
partnerships across our university, city, region, and other national ICRCs in newly advancing injury
prevention and the injury control field; and 3) ultimately reduce morbidity and mortality from unintentional
and intentional injuries level through the creation, dissemination, and translation of scientific knowledge,
the development of innovative and multi-level training and education programs, and the promotion of best
practices and evidence-based interventions. In doing this, the CCISP will establish a synergistic and
sustainable program in a premier research university; strengthen the scientific foundation for the
prevention of injury and violence; provide scholarly and technical support services for researchers,
trainees, practitioners, community groups, and policymakers; develop and deliver multifaceted training
and education programs; and promote evidence-based strategies and practices for reducing injuries.

Public health relevance
Columbia Center for Injury Science and Prevention – Project Narrative The overall objective of the Columbia Center for Injury Science and Prevention (CCISP) will be “science in service to safety”, leveraging the unique value of scientific inquiry in assembling a large group of university, community, and government partners around injury and violence strategies with the greatest potential to innovatively impact the safety and health of large populations. The Center will do this by promoting and performing innovative, cutting-edge injury research with real-world impact; building a new generation of injury scientists and practitioners in one of the world's leading training programs; and engaging in bidirectional sharing of expertise with policymakers and community partners to meaningfully reduce the burden of injuries and violence. The Center will integrate and sustain these three core activities — research, training, and outreach — to maximize its impact far beyond what could be achieved in separately conducting these activities.